Trans Spinal Delivery of Targeted Exosomal Formulation of Curcuminoids to Treat AD

TECHNICAL ABSTRACT
Neurodegenerative disorders affect over 40 million people worldwide and most are mediated by inflammation.
Even though several drugs are approved by the FDA for treating neurological disorders such as Alzheimer’s
disease (AD), their efficacy as AD therapeutics has not been realized as extremely low levels of the drug reach
the brain. The goal of this Phase I project is to develop a targeted delivery system for the bioactive curcuminoids,
curcumin (CUR) and bisdemethoxycurcumin (BDMC) to treat and mitigate the progression of neuroinflammatory
diseases, specifically AD. We will apply our extensive experience in exosomes, drug delivery, plant therapeutics
and inflammatory responses for efficient, targeted delivery of bioactive curcuminoids to the microenvironment of
the brain where progressive increase in inflammation, amyloid plaque formation and neurofibrillary tangles
ultimately leads to manifestation of AD. We hypothesize that the combined CUR and BDMC will be highly effective
at ameliorating neuroinflammation and aberrant AD-related gene expression returning these biomarkers to pre-
disease levels due to synergistic action via different mechanisms. We also hypothesize that rabies virus
glycoprotein (RVG)- and folic acid (FA)-functionalized exosomal formulations administered using a novel topical
trans-spinal (t.s.) route will provide enhanced targeting to AD-related regions of the brain, including the cortex and
hippocampus. Exosomes cross the BBB efficiently and areas of the brain associated with AD have high levels of
folate receptors (FRs). Thus, t.s.-administered RVG/FA-ExoCUR/BDMC will deliver higher payload to the brain
vs. conventional routes. Our hypotheses are supported by 1) effective drug loading of curcuminoids onto bovine
colostrum exosomes, 2) Higher levels (>14-fold) of curcuminoids in the mouse brain after FA-ExoCUR/BDMC t.s.
than p.o., 3) FA-exosomes can increase drug delivery to the brain which contains >20-fold higher expression of
FR than other tissues, 4) reduced NFκB accumulation and decreased abundance of phosphorylated Tau (pTau)
and amyloid precursor protein (APP) expression in brain lysates of mice treated orally with ExoCUR/BDMC in
concurrence with increased expression of brain-derived neurotrophic factors (BDNF) comparable to levels in age-
matched untreated WT mice while free CUR/BDMC was ineffective, and 5) higher brain accumulation of labeled
exosomes in mice treated via t.s. vs. i.v. route. Investigators experienced in exosomes, drug delivery, plant
therapeutics and animal models, leveraging experience of the neurologist, Dr. Robert Friedland in AD research,
will pursue the following specific aims: Aim 1. Optimize ExoCUR/BDMC formulations in vitro and determine
biodistribution in WT mice. Aim 2. Determine efficacy, toxicity and tissue levels of curcuminoids for
ExoCUR/BDMC formulations in AD mice. This project will provide proof-of-principle for the effectiveness of t.s.-
delivered RVG/FA-ExoCUR/BDMC on the modulation of key molecular targets and behavioral tests with AD
progression. In Phase II, we will conduct dose-finding and longer-term intervention using multiple rodent AD
models, chronic toxicity, etc. The t.s.-brain delivery could ultimately lead to the development of t.s. patches for AD.

Public health relevance
Narrative (Public Health Relevance Statement) In the proposed project, we will use a novel nano formulation of curcuminoids to mitigate neuroinflammation and attenuate neurological diseases with emphasis on Alzheimer's disease (AD). In our approach, curcuminoids, known for their potent anti-inflammatory activity and activities inhibiting early brain markers of AD including neurofibrillary tangles and amyloid plaque formation, will be sequestered in exosomes (natural nanoparticles), isolated from standardized bovine colostrum powder, to increase bioavailability. The exosomes will be decorated with folic acid whose receptors are expressed in high levels in the AD-related region of brain to target sub tissues such as cortex and hippocampus, and the formulation is delivered by a novel trans-spinal (t.s.) topical route for targeted brain delivery and the efficacy assessed using transgenic mouse model of AD.